Adapting, Pilot Testing a Behavioral Intervention to Incorporate Advances in HIV Prevention for Black Young MSM in Alabama

PROJECT SUMMARY
The overall goal of this 5-year Mentored Research Scientist Development K01-Award is to support Henna
Budhwani, PhD, MPH become an independent investigator in the field of HIV prevention. The proposed project
seeks to address the HIV crisis in Alabama, where rates of undiagnosed HIV in black young men who have sex
with men (YMSM, 18-29 years) exceed 20%. This project will adapt and test a behavioral intervention to promote
HIV rapid testing in the community, deliver culturally appropriate prevention education, offer sociostructural
supports, and refer eligible participants for pre-exposure prophylaxis (PrEP). Four training objectives are
proposed that are in lockstep with three specific aims. Objective 1 includes an intensive training and mentoring
plan in social theory including theories of intersectionality and emerging masculinities. Objective 2 includes in-
depth training on qualitative research methods including how to conduct focus groups, in-depth interviews, and
qualitative data analysis. Aim 1, which will be conducted after Objective 2, is to elucidate experiences, beliefs,
and predictors related to delivery and utilization of HIV testing and prevention services by black YMSM using
qualitative research methods, namely in-depth interviews with HIV outreach staff, focus groups with black YMSM,
and in-depth interviews with members of key sub-groups (e.g. transgender women) to inform the adaptation of
the Brothers Saving Brothers (BSB) intervention. Objective 3 includes didactic and hands-on training on how to
scientifically adapt HIV behavioral interventions using validated frameworks, such as intervention mapping. Aim
2 is to adapt the BSB intervention to include two HIV prevention tools (rapid testing and PrEP), to address
structural barriers, and to be acceptable to black YMSM in Alabama. Objective 4 includes comprehensive training
and mentoring in the field of implementation science. Aim 3, which concludes the proposed research study and
K01 project, is to conduct a hybrid type 1 effectiveness-implementation pilot study of the adapted intervention in
which the candidate will a) assess acceptability and feasibility of adapted BSB (aBSB); b) preliminarily estimate
effects on HIV prevention outcomes; and c) collect data on real-world implementation. These aims will be
accomplished by collaborating with two community-based organizations that are well-respected for their HIV
prevention work in study communities. This rigorous project includes intensive training at the candidate's home
university, the University of Alabama at Birmingham (UAB) and from other prominent institutions that offer very
specific training not found at UAB; engagement within the Adolescent Medicine Trials Network for HIV/AIDS
Interventions (ATN); comprehensive mentoring from senior HIV researchers with expertise in minority, youth,
and MSM health; and a thoughtful research strategy that addresses significant threats, high rates of undiagnosed
HIV and insufficient engagement with HIV prevention services, including PrEP, in black YMSM in Alabama. The
combination of the proposed mentoring and training with study findings will culminate in the candidate's
attainment of independence and development of a full-scale, implementation science R01 proposal to test aBSB.

Public health relevance
PROJECT NARRATIVE This research has the potential to make important contributions toward addressing some of the most significant and current public health challenges in the United States, namely high rates of HIV infection and HIV-related morbidity and mortality among black young men who have sex with men (YMSM, age 18-29). This study will do so by adapting a behavioral intervention, Brothers Saving Brothers (BSB), to include two HIV prevention tools (community-based rapid testing and pre-exposure prophylaxis, PrEP), include sociostructural supports, and for delivery in a new environment (Alabama in the United States Deep South), then testing the adapted intervention employing an implementation science hybrid type 1 effectiveness-implementation trial design. Results of this study, jointly with the formal training and mentoring the candidate will receive through this K01-Award, will prepare her to develop a robust R01 proposal to conduct a regional, full-scale implementation science randomized controlled trial of the adapted intervention across southern states and attain professional independence.